Defining the Circuit, Synaptic, and Molecular Mechanisms Linking Intracellular Ca2+ Release to Learning Using Subcellularly-Targeted Manipulations and Imaging Techniques in Dendrites in Vivo

Project Summary/Abstract
Candidate Goals and Mission Relevance: The applicant’s broad, long-term objective is to investigate how high-
(circuit/behavioral) and low- (subcellular/molecular) level organizational principles of the brain cooperate to drive
learning. The proposed research activities will build a foundation for this long-term goal and, in so doing, will
promote BRAIN 2025 Report goals by integrating new technological and conceptual approaches to causally link
intracellular Ca2+ release (ICR) from endoplasmic reticulum (ER) to neural activity dynamics and behavior.
Project description: Dendritic Ca2+ is central to neural plasticity mechanisms allowing animals to adapt to the
environment. ICR has long been thought to shape these mechanisms. The applicant recently carried out the first
investigation of ICR in mammalian neurons in vivo to uncover how this subcellular phenomenon shapes
experience-dependent feature selectivity across the dendritic arbor of pyramidal neurons (PNs) in mouse
hippocampal area CA1. This work raises important questions regarding when, where, and how ICR is engaged
to support learning. The applicant will address these questions in the following Aims:
Aim 1. Characterize plasticity-associated ER Ca2+ dynamics in dendrites in vivo (K99): To achieve this
Aim, the applicant will perform simultaneous dual-color, dual-plane in vivo 2-photon imaging of cytosolic and ER-
resident Ca2+ in dendrites of single CA1 PNs during head-fixed spatial navigation of novel virtual environments.
Aim 2. Define the synaptic logic tying intracellular Ca2+ release to in vivo synaptic plasticity (K99/R00):
The applicant will first create a novel molecular tool to optogenetically induce ICR (Aim 2.1; K99). The applicant
will then combine this precise interventional tool with single-cell imaging, inducible blockade of presynaptic
release, and optogenetic dampening of ICR to dissect the synaptic logic by which ICR participates in plasticity
induction in behaving mice. (Aim 2.2; R00).
Aim 3. Dissect excitatory circuit-molecular mechanisms driving intracellular Ca2+ release in vivo (R00):
The candidate will optogenetically activate specific excitatory projections onto distinct dendritic compartments of
single CA1PNs while monitoring ER Ca2+ dynamics in behaving mice. Local pharmacological manipulations will
dissect contributions of the two canonical pathways that convert presynaptic excitatory input to postsynaptic ICR.
Career development plan: The applicant will extend a highly complementary Co-Mentorship arrangement
between Drs. Franck Polleux and Attila Losonczy who possess deep expertise in cellular/molecular/genetic and
in vivo/behavioral approaches, respectively. The applicant will receive robust consultative support from Dr.
Stefano Fusi of Columbia’s Center for Theoretical Neuroscience and Dr. Darcy Peterka, Director of Cellular
Imaging at Columbia’s Zuckerman Institute. The applicant’s research and transition to independence will benefit
from this strong mentorship team, state-of-the-art facilities, all necessary equipment, and numerous Professional
Development resources offered through the Columbia Office of Postdoctoral Affairs, the Zuckerman Institute,
and the BRAIN Initiative.

Public health relevance
Project Narrative Neuronal calcium dysregulation has been linked to numerous neurological and neurodegenerative disorders including Alzheimer’s Disease, Parkinson Disease, and Autism. This proposal will employ innovative imaging approaches and precise casual manipulations, including a novel optogenetic tool, to test the role of the endoplasmic reticulum calcium store in brain function and learning & memory. In so doing, this work may shed light on the mechanism(s) by which neuronal calcium contributes to neurodegenerative disease.